Leveraging ambulatory assessment data and machine learning to develop personalized prediction models of suicidal ideation

A.7. PROJECT SUMMARY/ABSTRACT
The proposed research will leverage active and passive ambulatory assessment (AA) methods and machine
learning to develop personalized suicidal ideation (SI) prediction models among a clinical sample of youth at
high-risk for suicidality. This work is timely and important, given that suicide is currently the second-leading
cause of death among youth in the U.S., and rates of SI and suicidal behavior have risen steadily over the past
20 years. SI is a critical target for predictive models, as it is an identifiable, reliable, and modifiable antecedent
of suicidal behavior. Developing predictive models that can effectively predict SI may pave the way for just-in-
time interventions delivered at the precise time of peak risk, thus preventing suicidal behavior before it occurs.
However, despite decades of research, our ability to accurately predict SI remains poor, likely because
suicidality results from a complex interaction between contextualized dynamic processes that are largely
specific to each individual. Yet, most research has attempted to predict SI, a highly person-specific
phenomenon, from group-level data—which can adequately identify who is at risk but not when an individual is
at risk, which is critical for prevention. Thus, to improve our understanding and prediction of SI it is imperative
to take an approach that properly accounts for individual variability (i.e., personalized or precision medicine),
whereby the model is fit to the person rather than vice versa.
Advancements in ambulatory assessment, mobile computing, and machine learning allow for the collection,
management, and analysis of dynamic, high-resolution data required to develop personalized risk prediction
models. I propose to combine these methodological advancements to develop personalized models of SI
prediction. Specifically, among a population of youth at high-risk for suicidality, this study will use ecological
momentary assessment (EMA) to assess SI severity twice daily and collect continuous passive sensor data
from smartphones for 100 consecutive days. This project will map passively collected sensor data onto
variables that are empirically and theoretically linked to suicide risk, such as physical activity and mobility,
communication, and social interaction. This combination of daily ratings of SI severity and continuous passive
sensor data will provide the necessary data to develop personalized risk calculators that model each person’s
variability in SI severity as a function of passive sensor data. This study will further current conceptualizations
of suicide risk and prediction using advanced methodological and computational approaches, and provide
training in innovative methods that have the potential to predict SI risk in real-time, which is responsive to
Objectives 2.2 and 4.1 of NIMH’s Strategic Plan and holds tremendous promise for improving suicide
prevention efforts.

Public health relevance
A.8. PROJECT NARRATIVE This project aims to leverage machine learning and smartphone sensor data to develop prediction models of suicidal ideation (SI) that are personalized to the individual. Results of this project could pave the way for various promising interventions, such as just-in-time adaptive interventions and real-time monitoring of SI risk.